Evaluation of a polypeptide vaccine against Acinetobacter infection

Abstract
Acinetobacter baumannii (Ab) is a Gram-negative bacterium emerging as a major cause of nosocomial
infections. The most frequent clinical manifestations of Ab infection are ventilator-associated pneumonia and
catheter-related bloodstream/urinary infection, in addition to that of wounds. The rapid emergence of its multidrug
resistant phenotype makes Ab infection increasingly difficulty to treat, thus, there is a timely need to develop a
nonantibiotics-based intervention, e.g., vaccination, to control this bacterial disease. The goal of this proposal is
to further address the current gaps associated with Acinetobacter vaccine development by (1) assessing the
efficacy of novel chimeric polypeptide vaccines, (2) identifying potential immune correlates that can be used as
protective biomarkers and efficacy indicators for future vaccine development. Specifically, individual peptides
containing both T cell and B cell epitopes in our previously constructed protective Acinetobacter Multi-Epitope
Vaccines (AMEV1 and AMEV2), will be characterized for their immunogenicity and down selected to construct
a refined vaccine, AMEV3, for improved protection against pulmonary Acinetobacter infection. The AMEV3-
mediated protection will be characterized by assessing survival rates, reduction of bacterial burdens, and
preventing pathology in conventional C57BL/6 and humanized HLA-DR4 transgenic mice. Furthermore, the
protective role of antibodies generated by AMEV3 immunization will be studied by assessing passive
immunization efficacy, serum bactericidal activity, and enhancement of opsonophagocytic killing. Results of this
proposed study will advance our scientific knowledge of developing multivalent B/T epitope subunit vaccines and
gain insight into the protective mechanisms of immune sera against Ab infection.

Public health relevance
Project Narrative Acinetobacter baumannii is an important cause of multi-drug resistant nosocomial and combat related infections with high mortality. Immunotherapeutic alone or in combination with drugs can be a solution to prevent and treat MDR Acinetobacter infection. We propose to evaluate the potency of novel chimeric polypeptide vaccines against pneumonic Acinetobacter infection and delineate protective immunity to provide insights into the immunotherapeutic design against this emergent MDR bacterial pathogen.